Ultrasound-Interrogated Implantable Sensor for Intracranial Pressure Monitoring

Project Summary
Hydrocephalus is a disease characterized by excess cerebrospinal fluid (CSF) accumulation in the brain, leading
to elevated intracranial pressure (ICP). Current treatment options include the surgical implantation of a shunt
that relieves pressure by draining the excess CSF. However, almost 100% of implanted shunts fail within 10
years, resulting in a life-threatening condition necessitating additional surgery. Diagnosing shunt failure is
challenging due to non-specific symptoms and the lack of non-invasive shunt patency measurement, resulting
in unnecessary hospital visits and potential for permanent neurologic injury or death. ICP monitoring remains
one of the most definitive ways of diagnosing shunt failure, yet current methods are either highly invasive or lack
reliability. Thus, there is a critical need for a technology that enables ICP monitoring from directly within the
ventricles in an accurate, reliable and non-invasive manner. This project will develop a passive, shunt-mountable
ICP sensor that can be wirelessly interrogated with ultrasound in a safe, comfortable and reliable manner.
This project’s workflow is structured into three distinct yet interrelated aims. Mathematical models and finite
element simulations will be used to optimize the design an ICP sensor with high sensitivity and dynamic range.
The optimized designs will be fabricated, and their performance evaluated in benchtop experiments (aim 1). A
pre-clinical ultrasound system will be used to localize and wirelessly communicate with the sensor through a
skull phantom in water tank measurements (aim 2). Finally, the sensor electronics will be miniaturized, and
packaging will be optimized for implantable applications. The system will be tested in a hydrocephalus rodent
model and the results will be benchmarked against a commercial ICP sensor (aim 3).
The innovation lies in the pioneering use of acoustic frequency combs to sense and communicate ICP through
the skull, from a fully passive, implanted microscale sensor. Significantly, the proposal advances a fundamentally
new tool that will enable longitudinal, non-invasive and accurate ICP monitoring at the clinic or bedside using
ultrasound, thus eliminating the need for costly imaging, additional surgery, and patient distress. The ability to
reliably monitor ICP also provides access to a wealth of previously unavailable biometric data that might have
broader applicability for surveillance of brain tumor recurrence or for monitoring of traumatic brain injuries.
The K99 phase will provide dedicated training and career growth opportunities in implantable sensor
development, ultrasound imaging, bioelectronics, animal study design, small animal imaging and other dedicated
preparation needed to transition to a faculty position and an independent research career developing sensors
for continuous health monitoring. These training activities will provide the skills necessary to complete the
proposed sensor miniaturization, packaging and animal study in the R00 phase.

Public health relevance
Project Narrative Shunt failure is a common and debilitating complication in hydrocephalus patients, but diagnosing this failure is challenging and results in repeated imaging, surgical interventions and diminished quality of life. This work will develop and validate a novel, ultrasound interrogatable ICP sensor that enables non-invasive, continuous monitoring of shunt function, empowering clinicians to respond promptly to emerging complications and optimize patient care. By improving shunt function monitoring, the proposed approach can potentially transform hydrocephalus treatment, enhancing patient outcomes, reducing healthcare costs, and improving quality of life for individuals with hydrocephalus and their families.